ANTIGENICITY OF PHLIP-8 AND OTHER PHYSIOLOGICAL PEPTIDES

The purpose of this effort was to attempt to ascertain whether material in rat brain which was found to cross react with antisera to physalaemin would also cross-react with antisera to the structurally similar rabbit stomach peptide, PHLIP-8. Efforts to raise rabbit polyclonal antisera to protein conjugates of PHLIP-8 have been uniformly unsuccessful. Since PHLIP-8 is a rabbit stomach peptide containing an N-terminal pyroglutamate, the immune system of the rabbit may be unable to recognize it as a foreign antigen. As a result of difficulties in attempting to elicit antisera to PHLIP-8, this project is being terminated.